Automatic Pelvic Organ Delineation in Prostate Cancer Treatment

Automatic Pelvic Organ Delineation in Prostate Cancer Treatment
Abstract:
Fast, reliable and accurate delineation of pelvic organs in the planning and treatment images is a long-
standing, important and technically challenging problem. Its solution is highly required for state-of-the-art
image-guided radiation therapy planning and treatment, as better treatment decisions rely on timely
interpretation of anatomical information in the images. However, automatic segmentation in male pelvic regions
is always difficult due to 1) low contrast between prostate and surrounding organs, and 2) possibly disparate
shapes/appearances of bladder and rectum caused by tissue deformations. The goal of this project is to create
a set of novel machine learning tools to achieve accurate, reliable and efficient delineation of important pelvic
organs (e.g., prostate, bladder, and rectum) in different modalities (e.g., planning CT, treatment CT/CBCT,
and MRI) for radiotherapy of prostate cancer.
Planning CT. For automatic segmentation, landmark detection is often the first step in rapidly locating the
target organs. Thus, in Aim 1, we will create a novel joint landmark detection approach, based on both
random forests and auto-context model, to iteratively detect all landmarks and further coordinate their
detection results for achieving more accurate and consistent landmark detection results. After roughly locating
organs with the aid of those detected landmarks, the second step is to accurately segment boundaries of target
organs in the planning CT. Accordingly, in Aim 2, we will create a set of learning methods to a) first
simultaneously predict all pelvic organ boundaries in the planning CT with the regression forests trained by
labeled training data, and b) then segment all pelvic organs jointly by deforming their respective shape models.
In particular, to address the limitations of conventional deformable models in assuming simple Gaussian
distributions for organ shapes, a novel hierarchical sparse shape composition approach will be developed to
constrain shape models during deformable segmentation.
Treatment CT/CBCT. During the course of serial radiation treatments, to quantitatively record and monitor
the accumulated dose delivered to the patient, organs in the treatment image also need to be segmented.
Although methods proposed in Aims 1-2 can be simply applied, as done by many conventional methods, this
will lead to a) inconsistent landmark detection and b) inconsistent segmentations across different treatment
days because of possible large shape/appearance changes. Accordingly, in Aim 3, we will create a novel self-
learning mechanism to gradually learn and incorporate patient-specific information into both joint landmark
detection and deformable segmentation steps from the increasingly acquired treatment images of patient.
Thus, population data will gradually be replaced by the patient's own data to train personalized models.
MRI. To guide pelvic organ segmentation in the planning CT, MRI is now often acquired for selected
patients. To this end, in Aim 4, we will develop a) a prostate MRI segmentation method by using deep
learning to learn MRI-specific features for guiding landmark detection and deformable segmentation as
proposed in Aims 1-2; b) a novel collaborative MRI and CT segmentation algorithm for more accurate
segmentation of planning CT.
All our developed algorithms will be evaluated for their performance in clinical (treatment planning and
delivery) workflow for 130 patients in UNC Cancer Hospital and also hospitals of our consultants.
Benefit for Patient Care. Development of these segmentation tools will 1) dramatically accelerate the
clinical workflow, 2) reduce workload (i.e., manual interaction time) for physicians, and 3) lead to better
patient outcomes with reliable and accurate segmentations of target area and critical organs. Although these
tools cannot replace the expertise of physicians, they can be of great assistance to physicians.

Public health relevance
Narrative Description of Project This project aims to create a set of novel machine learning tools for accurate, reliable and efficient delineation of important pelvic organs (such as prostate, bladder, and rectum) in various imaging modalities to help radiotherapy of prostate cancer. To achieve this goal, we will create 1) a novel joint landmark detection and boundary prediction framework for accurate segmentation of the planning CT images, 2) an innovative updating mechanism for incorporating patient-specific information from previous treatment images of same patient to progressively improve treatment CT/CBCT segmentation, and 3) a deep-learning based framework for learning MRI-specific features for prostate MRI segmentation, as well as a novel method for collaborative MRI & planning CT segmentation. We will validate these methods on real patients in our clinical workflow. Besides, although these machine-learning tools are designed for radiotherapy of prostate cancer, they can also be easily extended to other new organs and new modalities after appropriate updating and training.